Microfluidic immunotherapy screening on a core needle biopsy

Project Abstract
We propose to develop a microfluidic device for direct personalized immunotherapy screening on a core
need biopsy. Since a number of various immunotherapy have been approved for cancer treatment, it is crucial
to select the right treatment among many immunotherapy options for a successful cancer therapy. Although
tissue microfluidic devices have shown potential as chemotherapy screening tools, none are suitable for
personalized immunotherapy screening. In this project, we will 1) develop a ‘core needle biopsy’ microfluidic
cassette and protocols for functional immune assays and 2) validate the microfluidic approach for screening
immune checkpoint blockade therapy with core needle biopsies from mouse and PDX breast tumors. We believe
the microfluidic immunotherapy screening on individual cancer patients’ tumor core biopsies will provide solid
guidance to oncologists in choosing the right immunotherapies for their patients.

Public health relevance
Project Narrative Despite expanded options in cancer immunotherapy, there is not a robust predictive assay method to match an individual cancer patient to the right therapy. This project aims to develop a microfluidic device and its operating protocol for screening cancer immunotherapy on a core needle biopsy. With the successful completion of this project, we will have a new predictive assay method for personalized cancer immunotherapy.